Characterizing the cognitive computations underlying spatial navigation

PROJECT SUMMARY
Deficits in spatial navigation are associated with a number of mental disorders including anxiety, autism,
depression, and schizophrenia. Previous work to investigate these deficits has relied on relatively coarse
behavioral measures, such as error rates and completion times, whose relation to the underlying neural
computations is unclear. Moreover, by using desktop Virtual Reality (VR) tasks, in which participants navigate
a virtual world while sitting at a computer, many spatial navigation experiments ignore one of the defining
features of spatial navigation – that it involves movement of the body through space. Because of these
limitations in measurement and ecological validity, the computational mechanisms underlying spatial
navigation deficits in mental illness are poorly understood.
The objective of this proposal is to develop and test new computational models and behavioral paradigms that
can pick apart the cognitive computations underlying spatial navigation. Our central hypothesis is that people
perform spatial navigation tasks using a mixture of two interacting processes: Path Integration, based on
integrating body-based cues about one’s own rotations and translations (e.g., sensory inputs about the
movement of one’s limbs), and Landmark Navigation, based on processing environmental cues (e.g. visual
landmarks). Work in this grant will develop computational models of both processes, including how estimates
from the two processes are combined. To test these models we make use of a new technology known as
immersive VR. In immersive VR, a virtual environment is rendered on a head-mounted display while
participants walk freely in a real room. Thus, participants experience identical body-based cues to real
navigation but with visual cues that are under experimental control. Using immersive VR, we will create two
behavioral tasks in which participants either turn (Rotation Task) or walk (Translation Task) to a remembered
heading or location in the dark. In the No Feedback condition (Aim 1), participants will complete these
movements with no visual feedback, allowing us to quantify Path Integration. In the Feedback condition (Aim
2), participants will receive a brief flash (300 ms) of visual information that is potentially offset relative to the
true location, allowing us to test how they combine Path Integration with Landmark Navigation from visual
cues. Finally, in both experiments, we will test whether performance is predictive of more general spatial
navigation ability using measures of real-world navigation ability (Aim 3).
The innovation in our proposal lies in both our experiments, which leverage new immersive VR technology to
induce mismatch between Path Integration and Landmark Navigation systems, and in our models, which
provide precise, concise, and quantitative descriptions of behavior. Beyond the foundational work in this grant
establishing the paradigms and models, our experiments are readily translatable to patients and animals,
allowing for insight into the clinical implications and neural mechanisms of deficits in spatial navigation.

Public health relevance
PROJECT NARRATIVE Spatial navigation is a crucial part of daily life but can be severely impaired in disorders of mental health. Here, we will develop and test new behavioral measures with ecologically validity and novel computational models to uncover the cognitive computations underlying spatial navigation. This work is relevant to public health as it will provide a theoretical framework for understanding spatial navigation deficits and in mental illness, potentially leading to better diagnostic tests and more targeted treatments for patients.